Colon Cancer Family Registry Cohort

PROJECT SUMMARY / ABSTRACT
The international, multi-site Colon Cancer Family Registry has established a cohort of approximately 37,400
colorectal cancer cases and their relatives, who are at increased risk of colorectal and other cancers, from over
10,800 families from the USA, Canada, and Australia. Existing standardized data from members include baseline
epidemiologic and follow-up questionnaires, clinical data, blood/buccal samples, tumor blocks, comprehensive
genotype data, including genome-wide association study (GWAS) data on population-based case- and control-
probands, extensive molecular characterization of the colorectal tumors, and genetic characterization of
participants for the cancer predisposing Lynch syndrome. All participants have been asked to participate in 5-
yearly follow-up, and with an 87% participation, have contributed a total of 470,000 person-life years and 1,000
incident colorectal and 4,700 incident other cancers. The resource has been used for 500 publications (132 in
the current project period) and 288 projects led by external investigators (56 in the past project period). In this
application, we seek funding for continued support of the cohort infrastructure, to continue follow-up of
participants, and to enhance the cohort with innovative characterization of value to future research on the
prevention, etiology and prognosis of CRC. We propose the following specific aims:
Aim 1: Preserve and encourage continued utilization of the Cohort and its resources
Aim 2: Update the cohort by follow-up of cohort members
Aim 3: Maintain and enhance the biorepository
Aim 4: Characterize incident colorectal cancers
Aim 5: Enhance and revitalize the cohort by recruiting the next generation
Aim 6: Enhance the cohort with microbiome data
Maintaining and enhancing our core infrastructure will facilitate our broad research agenda and will ensure that
the Colon Cancer Family Registry Cohort is increasingly valuable to research science and ultimately the public’s
health.

Public health relevance
PROJECT NARRATIVE The Colon Cancer Family Registry Cohort is well established and has been the resource of many studies of colorectal cancer. If the infrastructure grant is funded, the public health relevance gained by an additional 5- years of follow-up and innovative characterization to further enhance the cohort, will lead to a new wave of research for risk factors for the colorectal cancer, new ways of preventing the disease, and new ways to treat the disease.